Parkinson's Disease Neuroprotection Clinical Trial

DESCRIPTION (provided by applicant): This is a multicenter clinical trial to evaluate potential neuroprotective drugs in Parkinson's disease.

Public health relevance
RELEVANCE (See instructions): This is relative to public health as it evaluates potential neuroprotective drugs in Parkinson's disease.